Advanced Training in Nursing Outcomes Research

This is a continuation application for years 26 through 30 of the Advanced Training in Nursing Outcomes Research (T32NR007104) pre- and post-doctoral training program, funded by NINR. Over its lifetime, our T32 program has trained 32 PhDs and 43 postdoctoral trainees who are now doing research in more than 40 different institutions across 23 states. 95% of alumni are at research-intensive institutions, and 86% obtained research funding after completing their training. We seek funding to continue providing advanced training in nursing outcomes research for 5 predoctoral and 3 postdoctoral trainees each year. Our aim is to prepare an expert cohort of independent nurse investigators equipped with the advanced methods, data science tools, and conceptual grounding necessary to untangle the multiple ways in which policies, systems, and models of nursing care intersect and drive health outcomes across settings and populations. We also aim to increase the pipeline to PhD study by recruiting more undergraduates into research careers through expedited, tested, and well-supported 3-year BSN to PhD educational pathways. Housed in the Center for Health Outcomes and Policy Research (CHOPR) at Penn Nursing, the Outcomes Research T32 offers a vibrant, collaborative, and interdisciplinary team-science environment with unparalleled resources and learning opportunities including: 1) close mentorship from leading nurse scientists; 2) access to troves of unique data that can be used to study a wide array of populations, clinical settings, and policy challenges; 3) a large interdisciplinary T32 faculty with a deep reservoir of funded research and expertise; 4) collaborative cross-campus research centers and a world-class health system eager to partner and use evidence to transform practice; and 5) a scholarly community committed to solving big, complex problems with rigorous, collaborative science. Trainees learn through multiple modalities including: 1) a rich university curriculum and curated concentration courses for PhD students; 2) enrichment and supplementary support to ensure all postdocs have the skills they need to engage in and build their scholarship; 3) embedded real-world research experiences with experts; 4) small group and one-on-one support from data science and statistical staff; 5) multiple opportunities for hands-on application of data science skills; 6) stimulating T32 and cross-campus seminars with leaders in health policy and research; 7) engaging training in the responsible conduct of research and reproducibility; and 8) professional development and networking support to ensure smooth transitions to the next career stage. The nurse scientists completing our program will be prepared to employ rigorous state-of-the-art, multi-level research approaches to shape evidence-based policies, systems, and models of care that work. Likewise, they will be prepared to implement innovative policy and system reforms to ensure optimal health for all. The focus on policy, systems, care models, and data science aligns with NINR and NIH Priority Areas for Training.

Public health relevance
This proposal is for continuation of the highly successful Advanced Training in Nursing Outcomes Research program at Penn Nursing. We aim to develop a cohort of expert nurse scientists equipped with the advanced methods and data science approaches needed to conduct rigorous research that improves patient outcomes across all settings where nurses deliver care.